Cytomegalovirus Mitochondrial Inhibitor of Apoptosis

[unreadable] DESCRIPTION (provided by applicant): Human cytomegalovirus (CMV) causes devastating neurological disease in congenitally infected newborns. Many CMV gene products function to modulate and evade the host immune response to infection. CMV UL37x1 encodes a viral mitochondrial inhibitor of apoptosis (vMIA) that may be able to prevent or delay an apoptotic process in infected host cells. vMIA has been shown to block extrinsic and intrinsic death signals in the host cell, preventing mitochondrial membrane permeabilization and cytochrome c release. However, the mechanism of vMIA action is not known and it has no homology to cellular Bcl-2 family members, which have been shown to regulate cellular apoptotic signaling at mitochondria. We propose to characterize the mechanism of vMIA inhibition of apoptosis by mapping the amino acids required, elucidating cellular binding partners, and demonstrating the functional interaction of vMIA and its binding partners. Following this, we will determine the requirement for vMIA function in CMV replication by testing complementation of vMIA-deficient CMV infection with wild-type and mutated forms of vMIA, as well as other cellular or viral antiapoptotic proteins. [unreadable] [unreadable]